Genome-wide profiling of 5-hydroxymethylcytosine in aging liver

In our original proposal we reported the global increase in 5 hydroxymethylcytosine (5hmC) in aging livers.

In the past year, we have probed the hydroxymetholome landscape of the aging liver in greater detail. Using hydroxymethylcytosine DNA immunoprecipitation coupled to sequencing (hmeDIP-seq), we found that 5hmC accumulates in the bodies of genes involved in mitochondrial function. 5hmC also serves to restrict changes in gene expression during aging contributing to transcriptional stability.